CLINICAL IMMUNE SURVEY OF THE LONGITUDINAL PROJECT PARTICIPANTS

These studies use participants in the Baltimore Longitudinal Study of Aging (BLSA) and human cell lines to gain insight into the biochemical and molecular mechanisms underlying age-associated changes in immune function. Recent data indicates that human T lymphocytes activated through different cellular pathways display distinctive patterns of protein phosphorylation, cytokine synthesis and gene expression, only some of which are age-affected.